Investigation of ATV-Based Heterobifunctional Degraders to Combat Growing HIV-1 PR Inhibitor Resistance

PROJECT SUMMARY/ABSTRACT
Heterobifunctional targeted protein degraders (TPDs) offer advantages over traditional occupancy-based
inhibitors including a unique catalytic mechanism of action (MOA), greater target selectivity, and a reduced
probability for resistance development. TPDs are known to effectively target not only cytosolic proteins, but also
nuclear and membrane-bound proteins. This therapeutic modality shows great promise for treating drug-resistant
cancers and autoimmune diseases but has seen only limited application in antiviral drug discovery. HIV-1
protease (PR) is essential for proteolytic cleavage of Gag and Gag-Pol polyproteins and, thus, virion maturation
and infectivity. Gag-Pol forms dynamic dimers at plasma membrane assembly/budding sites, allowing the
embedded precursor PR to dimerize as a prerequisite for auto-processing. We identified precursor PR/Gag-Pol
as a promising target for protease inhibitor (PI)-based TPDs. The widely used HIV-1 PI, Atazanavir (ATV), is
amenable to conjugation with linkers and ubiquitin E3 ligase recruiting ligands to serve as prototype HIV-1 TPDs.
Importantly, ATV inhibits activity of mature PR as well as autoprocessing of precursor PR/Gag-Pol during the
assembly and budding processes. The OBJECTIVE of this study is to show proof-of-concept that HIV-1 Gag-
Pol assembling on the inner leaflet of the plasma membrane can be targeted for aberrant ubiquitination,
degradation, and/or inhibition, thereby impairing HIV infectivity. Importantly, due to TPDs’ established MOA, even
low-affinity Gag-Pol/TPD interactions are likely to lead to impaired Gag-Pol function. Thus, we pose the
HYPOTHESIS that novel ATV-based TPDs will not only augment the inhibition of ATV-sensitive HIV-1 strains
compared to ATV, but also exhibit increased and broader biological activity against drug-resistant variants.
The objective of AIM 1 is to design and synthesize ATV-based TPDs built on state-of-the-art computational
methods and predictive physicochemical properties currently accepted for in vivo active TPDs. Our approach
will feature a modular TPD design to establish the appropriate ATV attachment point, E3 ligase recruiter, and
length and composition of linker required for HIV-1 Gag-Pol ubiquitination/proteasomal degradation. The goal
of AIM 2 is to provide proof-of-concept that ATV-TPDs exert superior activity versus ATV against wild type and
PI-resistant HIV-1 strains. We will systematically screen four series of novel ATV-TPD for activity in vitro, in
single-round infectivity, and in multi-round replication assays to identify the most promising ATV-TPD candidates.
The latter will be tested in complementary limited-scope mechanistic studies, including comparing ATV-TPDs
with analogs bearing inactive E3-ligase ligands, to probe if antiviral activity is consistent with the proposed MOA.
The IMPACT will be TPDs targeting HIV-1 Gag-Pol and precursor PR that limit infectivity and replication through
a mechanism distinct from occupancy-based HIV-1 PI. This will spur the future development of efficacious
regimens against PI-resistant HIV strains with reduced susceptibility for resistance development.

Public health relevance
PROJECT NARRATIVE HIV-1 protease inhibitors (PI) are key components of long-term antiretroviral therapies; however, these drugs are becoming less effective in treating and preventing HIV infections as viral resistance to the inhibitors expands. This high-risk/high-reward proof-of-concept study will target the essential HIV protease (PR) within Gag-Pol polyprotein precursors for ubiquitination and degradation by converting established HIV-1 protease inhibitor molecules into targeted protein degraders (TPDs). Successful completion of this study will underpin future development of novel therapeutic approaches based on targeted destruction of HIV proteins, with the goal to limit the inexorable development of drug- and treatment-resistant HIV associated with current drug regimens.